MD Anderson Summer Program in Cancer Research (SPCR)

PROJECT SUMMARY
The Department of Epigenetics and Molecular Carcinogenesis (EMC) at the University of Texas MD
Anderson Cancer Center has hosted a hands-on laboratory-based Summer Program in Cancer Research
(SPCR) for academically accomplished undergraduates for more than 25 years. Participating faculty members
are not only committed educators but also internationally recognized experts in the fields of cancer epigenetics,
genetics and genomics. The goal of the SPCR is to provide talented undergraduate students with a research
project-based laboratory experience and exposure to the different disciplines working to address the causes,
diagnosis, prevention, and treatment of cancer with an emphasis on epigenetic mechanisms. The overall
Program objective is to promote careers in cancer research and clinical oncology, which is in line with the NCI
mission to attract and train the best minds to become the next generation of cancer researchers. This goal will
be accomplished through a formalized 10-week summer program in which students will undertake an
individualized research project supervised by a faculty mentor. In addition to bench-side research, SPCR
students will participate in a series of lectures, seminars, and discussion sessions to introduce them to core
concepts in cancer biology and epigenetics. An epigenetics focused lecture series will cover “DNA methylation
and Cancer,” “Histone code and Cancer,” “Artificial intelligence and bioinformatics in epigenetics research,” and
“Cancer therapies targeting Epigenetic regulators,” which will be given by faculty members. “Works-in-Progress
(WIP)” seminars, given by department faculty and trainees on their day-to-day research, will also be attended by
the students. Discussion sessions led by WIP speakers and program directors with SPCR students immediately
after these seminars will focus on the laboratory techniques utilized by the speaker, to introduce interns to
methods relevant to epigenetics research. The Program incorporates several “field trip” experiences, designed
to expand students’ horizons, such as a Graduate Student Research Day and a tour of the MD Anderson Keeling
Center for Comparative Medicine, one of the premier non-human primate research facilities in the country and
an important translational research component of MD Anderson. Students will also be exposed to career paths
taken by diverse investigators at MD Anderson through a series of presentations entitled “Career Conversations.”
In preparation for a culminating Scientific Symposium, where students present their research projects to
departmental faculty, trainees, and staff, interns will learn how to organize a scientific presentation, including
background information, hypothesis, methods, results, and conclusions, and will hone their oral communication
skills. Past programmatic evaluations demonstrate that the SPCR is an important contributor to the career
development of participating students and influenced their decision and ability to pursue graduate or other
training leading to careers in cancer-related research and medicine.

Public health relevance
PROJECT NARRATIVE The Summer Program in Cancer Research will provide a 10-week, authentic, hypothesis-driven, hands-on, cancer research experience to each of 17 talented undergraduate students, early in their professional paths, to promote careers and/or further education in cancer and epigenetics research, health care, and oncology. Under the direction of faculty and laboratory staff mentors, students will learn laboratory techniques and research procedures as they gain exposure to innovative research tools and resources. This experience/training will increasing their technical acuity, communication skills and establishing the self-confidence required to advance in the field of cancer research.